Pediatric Medical Devices Public-Private Partnership (PMD-PPP) Design Phase

FNIH RESPONSE TO THE REQUEST FOR NEGOTIATION
To develop a Public-Private Partnership
to support pediatric medical device development and commercialization
June 29, 2023
Abstract (from “Introduction” of the Proposal Memo)
As requested in the Request for Negotiation to Develop a Public-Private Partnership to support pediatric
medical device development and commercialization submitted by the NIH, the FNIH provides herein
information concerning the work the FNIH will undertake until February 28, 2025, and the costs to fund
that work. This period will cover the Design Phase of the PMD-PPP and activities needed to support the
Transition Phase period while the proposed implementation of the PMD-PPP is reviewed by NIH and FNIH
leadership. The launch of the Implementation Phase itself is subject to future approval by the NIH and the
FNIH through the RFC process and thus those activities are out of scope for this RFN response.